Leveraging Families to Promote Healthy Socio-Emotional Development in Children

PROJECT SUMMARY/ABSTRACT
The family unit is an important yet understudied point of intervention that can be leveraged to promote critical understandings about fairness, foster empathy and cooperation with others, and reduce harmful anti-social behaviors (e.g. bullying, harassment) among young children. Teaching and socialization practices among caregivers are critical to support prosocial behaviors, such as encouraging positive peer relationships and interactions, which have been shown to improve social/emotional well-being among children. This project is innovative by focusing on practices that families can engage in to encourage prosocial behaviors and prevent the perpetration of those that are harmful, which have been shown to benefit all children. We will recruit a national sample of primary caregivers and their K-2nd grade children. Qualitative data from focus groups will enhance the scientific basis for our intervention program—a multi-module app that guides parents in having conversations with their children about treating others fairly, resolving conflict, and principles of cooperation, and provides strategies on how to foster empathy. We test the intervention using a rigorous randomized attention/wait-list controlled trial design. The design of the intervention is based on research indicating that among children, positive intergroup contact with outgroup members, including vicarious engagement, can prevent or reduce anti-outgroup behaviors particularly when contact is based on common goals, cooperation rather than competition, and supported by external authorities. We collect a broad range of measures using mixed-methods, through one-one-one interviews with caregivers and children and dyadic interviews. Adapting the intervention for delivery via a downloadable app facilitates scalability resulting in greater potential to have wide social impact. This work expands the scope of the science on how teaching and socialization practices within families can enhance children’s developmental and health outcomes.

Public health relevance
PROJECT NARRATIVE This study focuses on the role that families can have in promoting children’s socio-emotional well-being and health through teaching and socialization about the importance of prosocial behaviors and attitudes. We test the efficacy of a multi-module app in guiding conversations between caregivers and children about fairness and empathy, which we posit will be linked to improved health outcomes and other secondary benefits to families. It is hypothesized that the app-based intervention we propose will enhance the quality of relationships between caregivers and their children, as well as between children and their peers, which are important mechanisms to promote children’s healthy development.